Improving chemotherapy of castration-resistant prostate cancer.

Title: Improving chemotherapy of castration-resistant prostate cancer
Abstract
Androgen receptor (AR) signaling is essential for prostate cancer (PCa) development and growth, even in
castration-resistant PCa (CRPC), the lethal stage of the disease. Docetaxel is the standard treatment for CRPC
patients due to a combination of mitotic catastrophe and inhibition of AR signaling. Androgen signaling inhibitors
(ASI) are also used to treat CRPC post-docetaxel with limited success. Therefore, it is urgent to identify new
targets and develop novel approaches to treat CRPC that are resistant to the existing therapies. Brd4, a
conserved member of the bromodomain and extraterminal (BET) family of chromatin readers, promotes gene
transcription via interacting with core positive transcription elongation factor (P-TEFb), consisting of Cdk9 and
cyclin T1. Significantly, AR signaling-competent CRPC cells are preferentially sensitive to Brd4 inhibitor JQ1 as
JQ1 treatment disrupts AR recruitment to target gene loci, thus resulting in inhibition of AR signaling directly.
Furthermore, JQ1 enhances the efficacy of ASI in PCa. Loss-of-function mutations in E3 ubiquitin ligase
substrate-binding adaptor speckle-type POZ protein (SPOP) cause stabilization of Brd4 and JQ1 resistance.
Thus, it will be of clinical significance to understand the regulation mechanism of Brd4 regulation and to develop
a new approach to cause Brd4 degradation even in the presence of SPOP mutations. The long-term goals of
this study are to identify novel and druggable signaling pathways that offer more effective treatment options for
patients with therapy-resistant CRPC. The objective is to define the role of polo-like kinase 1 (Plk1) in regulating
Brd4 degradation and AR signaling, and to exploit this unique mechanism to develop a novel approach for
treatment. Our preliminary data show that Plk1 phosphorylation of Brd4 leads to its protein degradation even in
the presence of SPOP mutations. The central hypothesis is that Plk1-associated phosphorylation of Brd4 results
in its degradation, thus docetaxel-associated Plk1 elevation is one approach to overcome resistance to Brd4
inhibitors. This hypothesis will be tested by pursuing three Specific Aims - (1) to dissect how Plk1 phosphorylation
of Brd4 regulates AR signaling; (2) to understand how Brd4 phosphorylation contributes to PCa cell proliferation;
and (3) to analyze clinical significance of Plk1-associated Brd4 phosphorylation. These complementary aims will
be accomplished using biochemical analyses of signaling intermediates and employing genetic strategies with
PCa mouse models, culture systems and PCa xenograft methodologies. The rationale for the research is that it
will be the first to probe the importance of Plk1 to Brd4 and AR signaling and to examine whether a combination
of docetaxel and Brd4 inhibitor ABBV-744 is a novel approach to treat ASI-resistant CRPC. This contribution is
significant because it will (i) define the molecular mechanism by which Plk1 regulates Brd4 degradation and
AR signaling; and (ii) validate docetaxel as a therapeutic agent to enhance the efficacy of Brd4 inhibitors.

Public health relevance
Narrative The proposed research is relevant to public health because it focuses on discovery of novel signaling pathways that drive castration-resistant prostate cancer. These studies will establish new avenues of investigation to develop improved therapeutics to treat this deadly disease and to greatly improve patient outcome. Thus, the proposed research is relevant to NIH's mission of fostering creative discoveries and innovative research strategies for protecting and improving health and reducing the burdens associated with cancer.